Nitric oxide-releasing glycosaminoglycans for treating complex wounds

SUMMARY
The delayed healing observed in chronic wounds is exacerbated by persistent microbial infections and non-
resolving inflammation. Furthermore, the emergence of antibiotic-resistant bacteria has limited the use of these
agents for treating infected wounds. Adding to the complexity of chronic wound treatment, infection is usually
not the sole cause of wound chronicity. Underlying diseases such as diabetes leave individuals prone to infection
by affecting the host immune responses, including inflammatory cell migration, cell signaling, and effector
function. An ideal wound healing therapeutic must thus address the impairment of the host immune response while also
possessing antibacterial activity. Due to the high prevalence of chronic wound-related amputations and mortality, the need
for such a multi-action therapeutic is urgent. Nitric oxide (NO) is an endogenous signaling molecule that represents
an attractive, alternative therapeutic for treating chronic wounds due to its innate antibacterial and
immunomodulatory function in human physiology. We have pioneered the development of macromolecular
NO donor systems that store and spontaneously release NO in dissolved form (i.e., not as a gas) at
therapeutically relevant levels. We now aim to develop NO-releasing glycosaminoglycan biopolymers (GAGs)
as wound healing therapeutics. GAGs are naturally occurring biopolymers that are immunomodulatory and
known to be involved in wound healing physiology. We hypothesize that combining the multi-faceted roles of
GAGs and NO will allow for a therapeutic that effectively: 1) eradicates wound pathogens; 2) modulates
inflammation; and, 3) promotes re-epithelialization to facilitate timely wound closure.
The objective of this project is to define the roles of GAG molecular weight, sulfation patterns and NO-release
properties as they related to antibacterial and pro-wound healing activities. In developing a new class of wound-
healing therapeutics, we will characterize cell proliferation, adhesion, and migration as a function of NO
payloads and GAG structure using cell culture assays and a three-dimensional human skin tissue model. We
will evaluate the effect of NO-releasing GAGs on innate immune cell plasticity using primary human cell
systems. We will then determine the therapeutic efficacy of the most promising NO-releasing GAG derivatives
on antibacterial action, inflammation, and wound closure as a function of infection and diabetes. An iterative
approach will be taken to determine the optimal dose, time, and frequency of therapeutic intervention. A
systems biology approach will be used to elucidate mechanisms of efficacy and failure, which will inform clinical
translation of these therapeutic approaches. This new research program will allow us to build upon our previous
successes in developing NO-releasing macromolecular scaffolds, but now with a focus on wound healing. Our
goal is to develop a therapeutic that treats infection and promotes wound healing in populations afflicted by chronic wounds.

Public health relevance
NARRATIVE An ideal therapeutic for chronic wounds must address the impairment of the host immune response while also possessing antibacterial activity whereby due to the high prevalence of chronic wound-related amputations and mortality, the need for this dual-action therapeutic is urgent. We have recently begun to develope NO-releasing glycosaminoglycan biopolymers whose multi-faceted roles will allow for a wound healing therapeutic that: 1) eradicates common wound pathogens with minimal toxicity to cells and tissues; 2) modulates wound-related inflammation; and, 3) promotes re-epithelialization to facilitate wound closure. Here we will build upon our previous successes in developing NO-releasing therapeutics and understanding their benefits in wound healing to help populations afflicted by non-healing chronic wounds, including those with type 2 diabetes.